Reducing Suicide Risk in Older Veterans with Mental Health Disorders using Problem Solving Therapy

The proposed randomized control trial will examine the efficacy of a brief behavioral treatment for reducing
suicidal ideation and for increasing reasons for living in older Veterans at risk for suicide. Two common issues
in older adults, functional disability and executive dysfunction, increase suicide risk and will be examined as
moderators and mediators of treatment outcomes. The proposed study will examine Problem Solving Therapy
(PST) using a protocol that teaches skills to address emotional and practical barriers to effective problem
solving. The VA usual care practice of collaborative safety planning will be the control condition, herein referred
to as enhanced usual care (EUC). For participant safety, Veterans enrolled in PST will also receive EUC. The
study design is random assignment to the treatment, PST plus EUC, or the control condition, EUC only. Both
the treatment and the control are evidence-based interventions delivered in six sessions. The study will occur
at VA Palo Alto (primary site) and VA Syracuse/VA Canandaigua (secondary site).
Longitudinal assessment of suicidal ideation and reasons for living will occur at eleven timepoints:
baseline, after each of the six weekly treatment sessions, posttreatment (7 weeks), at 1-, 3-, and 6-
month follow-up. The recruitment goal is 150 Veterans over a five-year period with 75 participants
randomized to each treatment. Veterans must be 60 years or older, report suicide ideation, and meet
diagnostic criteria for a depressive disorder, anxiety disorder, and/or posttraumatic stress disorder to be
eligible. Veterans will be excluded and referred for other services if they have psychotic symptoms,
bipolar disorder, severe OCD, or elevated symptoms indicative of borderline personality disorder; an
alcohol/substance use disorder; severe or unstable medical conditions; recent head injury (past year)
or history of a head injury with loss of consciousness for 24 or more hours; terminal illness; positive
cognitive screen indicative of possible dementia; or if they are unable to participate in the study or
follow-up sessions. Recruitment will occur through multiple strategies at VA, Vet centers, and in the
community to ensure the feasibility of recruiting a total of 75 Veterans at each site. To meet this recruitment
goal, the primary and secondary site will each enroll 2 to 3 Veterans per month.
Fidelity ratings of audiotaped treatment sessions will be made by independent raters on 20% of sessions.
Mixed effects modeling will be used to estimate the effect of treatment versus the control for the outcomes of
suicidal ideation and reasons for living. Models will covary for demographics, medical and psychiatric
comorbidity, and psychotropic use. For the primary aim, models will determine whether PST plus EUC is
associated with a larger treatment effect compared with EUC only for suicidal ideation and reasons for living.
Secondary aims will determine if baseline functional disability and executive dysfunction moderate treatment
outcomes, and whether a change in these two variables from baseline to posttreatment are significantly
associated with (mediate) change in suicidal ideation and reasons for living. The tertiary aims will use
qualitative methods to assess Veteran satisfaction with the treatment and control including the types of
problems with which treatment helped them, and suggestions for improving it for future Veterans. The current
VA/DoD Clinical Practice Guidelines (CPGs) for suicide do not list treatment options specifically for older
Veterans despite the majority of VHA patients being 55 years or older. Thus, evidence-based outcomes from
the proposed work have potential to inform the CPG recommendations for using PST with Safety Planning
and/or Safety Planning alone with older Veterans. Dissemination of the treatment could be supported by
expanding existing VA training infrastructure in problem solving based interventions.

Public health relevance
Suicide is a national crisis, especially among older Veterans for whom evidence-based suicide prevention efforts are lacking. This proposal responds to the national priority to develop and improve interventions for suicide prevention, with a focus on at-risk older Veterans. The randomized control trial will compare VA usual care, which is suicide safety planning, with brief Problem Solving Therapy and suicide safety planning. This study uses Problem Solving Therapy because it has support from our pilot data and from secondary data analysis from other studies for reducing late life suicide risk. This treatment also has support for alleviating two key risk factors for late life suicide risk, functional disability and executive dysfunction, and thus this study will examine how older Veterans with varying levels of functional disability and executive functioning respond to treatment to inform future targeted implementation. In accordance with national priorities, existing infrastructure in Problem Solving Training could be expanded to support more rapid VA-wide implementation.